Household transmission of the human gut microbiota after antibiotic exposure

PROJECT SUMMARY/ABSTRACT
Humans constantly encounter microbes in their diets and environments, but only a tiny fraction of these
microbes take up long-term residence in the adult gut microbiome. Microbiome therapeutics like probiotics and
fecal microbiota transplants often seek to introduce new, desirable microbes, but these strains are frequently
lost and fail to stably colonize existing communities. Understanding the ecological interactions that affect
colonization and transmission is crucial for designing successful targeted microbiome therapeutics. Ecological
theory predicts that factors like cross-feeding, nutrient competition, and priority effects may affect the ability of
new microbes to colonize established communities, but there remain few examples of ecological interactions
that affect colonization in the human gut microbiome. Here, we propose to investigate ecological interactions in
microbial communities that affect colonization and transmission in natural and experimental gut microbial
communities. We plan to focus on households, which are natural settings of microbial transmission. We have
already recruited a longitudinal household cohort to document transmission after antibiotic exposure in the adult
gut microbiome which allows us to determine how disturbances affect strain colonization. We will also use a
novel experimental system to test the role of ecological factors like community diversity, ecological drift, and
environmental perturbations. First, we will track transmission events within households in the human gut
microbiome after antibiotic exposure by performing metagenomic sequencing of stool samples from the
household cohort. By analyzing these data, we will identify transmission events that occur before and after
antibiotic exposure, and we will track the trajectories of mutations that arise after strain transmission, as strains
propagate in new hosts and communities. Next, we will characterize the effects of ecological drift and community
diversity on transmission in ex vivo microbial communities. We have generated ex vivo communities from stool
samples collected from our household cohort, and we will mix pairs of communities to evaluate the effects of
strain dosage and community diversity on transmission. Finally, we will systematically mix ex vivo communities
to identify strains capable of colonizing communities before and after antibiotic perturbation. Together, this work
will provide important new information about the ecological factors that shape microbial colonization and
transmission. The initial, exploratory work proposed here will also pave the way for future work that uses these
collections of gut-derived communities to identify and characterize molecular and metabolic interactions between
strains that affect microbial colonization, helping us design more effective, targeted microbiome therapeutics.

Public health relevance
PROJECT NARRATIVE Humans constantly encounter new microbes in their diets and environments, but only a tiny fraction of these microbes become long-term residents of the adult gut microbiome. Understanding the ecological forces that shape microbial colonization and transmission is essential for developing targeted microbiome therapeutics. We will study colonization and transmission dynamics in a longitudinal household cohort after antibiotic exposure, and we will perform experiments in stool-derived microbial communities to test the ecological factors that affect microbial colonization.